Core C: Biostatistics and Bioinformatics Core

PROJECT SUMMARY – BIOSTATISTICS/BIOINFORMATICS CORE (CORE C)
The Biostatistics/Bioinformatics Core (Core C) of the Hillman Cancer Center (HCC) HN SPORE provides
services for the design of experiments and the analysis of in vitro, in vivo, clinical, translational and -omics
data. The investigators and staff of both segments of the Core have significant experience in research in head
and neck cancers, so that data are analyzed in the appropriate scientific context, increasing the Core's
efficiency and effectiveness compared to general purpose data analysis services. Biostatistics and
Bioinformatics combines classic statistical techniques with contemporary Bayesian, machine learning and
genomics methods to ensure that every research project, Developmental Research Program and Career
Development Program awardee in the SPORE has access to the most appropriate analyses. The Core will
also work closely with Core A (OSD) and Core B to ensure that data flows between laboratories, clinics and
analysts are efficient and that data and resource sharing can be effective and comprehensive.
This Core C Co-Directors are Dr. Daniel Normolle (Biostatistics) and Dr. Riyue Bao (Bioinformatics) who
have assembled an excellent team to help achieve the goals of the HN SPORE.

Public health relevance
PROJECT NARRATIVE – BIOSTATISTICS/BIOINFORMATICS CORE (CORE C) The Biostatistics/Bioinformatics Core (Core C) provides specialized analysis services to the clinical, laboratory, translational and “-omics” research projects of the UPMC Hillman Cancer Center HN SPORE to ensure that experiments are efficiently designed and data are analyzed in a rigorous and reproducible fashion by analysts familiar with cancer in general and head and neck squamous cell carcinoma in particular.